Patterns of Sleep Restriction and Recovery: The Inflammatory Resolution Pathways

PROJECT SUMMARY
Low-grade or unresolved inflammation is involved in the pathogenesis of many human diseases. Common
sleep patterns of restricting sleep during the work week and ‘catching up’ on sleep over the weekend lead to
inflammatory upregulation that does not recover completely after the weekend.
Goal of this proposal is to investigate, for the first time, inflammatory resolution pathways. Inflammatory
resolution mediators, such as resolvins, are derived from omega-3 free fatty acids and actively ‘turn-off’
inflammation. Based on preliminary data from our lab, we hypothesize that common sleep restriction-
recovery patterns disrupt inflammatory resolution pathways, making it difficult to return to
inflammatory homeostasis. If true, pharmacologically increasing the body’s natural production of
endogenous inflammatory resolution mediators may one day provide a way to reduce the detrimental
inflammatory consequences of common sleep restriction-recovery patterns.
The hypothesis will be tested using an experimental model that mimics common patterns of restricting
sleep on week days and ‘catching up’ on sleep on the weekend. The proposal will further utilize the unique
ability of low-dose aspirin, which – like no other non-steroidal anti-inflammatory drug – is able to activate
inflammatory resolution pathways. Healthy women and men between the ages of 18 to 50 years will be tested
under three 10-day long in-hospital stays, during which they will be exposed to control sleep or common
patterns of sleep restriction-recovery. The two sleep restriction-recovery stays will be combined with
preemptive administration of low-dose aspirin or placebo. Aim 1 will investigate whether exposure to
commonly experienced sleep patterns of sleep restriction followed by recovery sleep will not only activate
inflammatory (e.g., interleukin-6), but disrupt inflammatory resolution pathways (e.g., resolvins), as well. Aim 2
will test that activation of inflammatory resolution pathways by aspirin dampens the inflammatory response to
sleep restriction. Aim 3 is target-unspecific and will profile a wide range of resolution lipid mediators using a
liquid chromatography/tandem mass spectrometry (LC-MS/MS) platform, which may fuel the search of a
biomarker to be used in the monitoring of sleep health.
Targeting inflammatory resolution pathways could provide a novel, non-behavioral strategy to mitigate both
inflammatory consequences and future disease risks in those undergoing periods of sleep restriction-recovery
patterns – a behavior pattern that is unlikely to be eradicated in the near future, as changes in sleep are
generally difficult to make and to maintain.

Public health relevance
PROJECT NARRATIVE Goal of this project is to investigate, for the first time, whether increases in inflammation that result from common patterns of restricting sleep on week nights and catching up on sleep over the weekend are caused by disruption in the newly discovered inflammatory resolution pathways. These pathways are crucial in the active termination of the inflammatory response, and their disruption may contribute to ongoing unresolved inflammation, which has been observed not only during periods of sleep restriction, but also after recovery sleep has been obtained. If our hypothesis is true, it is possible that increasing the body’s natural production of endogenous, inflammatory resolution mediators may provide a non-behavioral strategy to limit the inflammatory consequences in those undergoing periods of sleep restriction with intermittent recovery sleep.